Admin Supplemental for ADRC Core D

Summary/Abstract
Scientific progress towards prevention, diagnosis and treatment of complex neurodegenerative,
neuropsychiatric and neurodevelopmental disorders is dependent on the availability of well-annotated and
catalogued postmortem human brain tissue samples. In order to maximize community-derived brain donations
from patients with Alzheimer’s disease (AD), vascular dementia, unspecified dementia and cognitively normal
controls, a working group was established to explore a possible collaboration between the NIH Neurobiobank
(NBB) network and Alzheimer’s disease research center (ADRC) neuropathology cores (NP core). The objective
of this collaboration is to optimize access to high-quality tissue samples by integrating and taking advantage of
existing infrastructures. In 2019, the University of Pittsburgh ADRC (PITT-ADRC) was chosen as one of three
pilot sites for this project, with the goal to establish eligibility criteria, recruitment processes and standard
operating procedures to align data collection and tissue distribution mechanisms with NBB protocols.
Our proposed approach to fulfill the goals of this ADRC-NBB pilot project is outlined in the following six
specific aims: 1) Develop and implement a strategy to recruit brain donations through the Brain Donor Project
into the ADRC neuropathology core network. 2) Perform detailed neuropathological diagnostic evaluations of all
banked cases using state-of-the-art consensus criteria and provide feedback to families. 3) Obtain clinical
information and ancillary laboratory tests in alignment with NIH NBB protocols. 4) Upload demographic, clinical
and neuropathology data to the NIH NBB case catalog. 5) Distribute tissue samples to the research community
in response to requests received through the NIH Neurobiobank portal. 6) Enhance the banking, neuropathology
data sharing via NACC and tissue distribution of well-characterized autopsy cases from University of Pittsburgh
research study participants and hospital patients with neurodegenerative disorders.
Through these aims and in collaboration with the other pilot sites, we will demonstrate the feasibility of
establishing ADRC NP cores as affiliate sites of the NIH NBB network and of developing a streamlined process
to banking of non-ADRC cases. Our finalized approach will be made available to the wider ADRC community to
allow other interested NP cores to join this collaborative brain banking program and further maximize brain
donations. In addition, we will enhance brain donations from non-ADRC subjects with AD and related dementias
from local neurology clinics as well as research cohorts with strong emphasis on subjects with prior neuroimaging
studies, taking advantage of the recently created Brief Data Set at the National Alzheimer Coordinating Center
(NACC) to increase accessibility to these cases by the wider research community and to promote tissue sharing.

Public health relevance
Project Narrative Well characterized postmortem brain tissue is an invaluable resource for research into mechanisms and treatment targets for neurodegenerative disorders. The goal of this application is to enhance recruitment of brain donors and accessibility of brain tissue through a collaboration between NIH Neurobiobanks and ADRCs.